TASK ORDER 6R - ASTHMA AND RESPIRATORY DISEASE RESEARCH (ARDR)

The purpose of this task order is to provide analytic support and expertise for the design and implementation of statistical analyses and the development of manuscripts pertaining to the National Health and Nutrition Examination Survey (NHANES) data, including the Allergy Component.